Investigating Cis- and Trans-Genetic Regulation of Brain Transcriptomics and Proteomics Associated with AD/ADRD

PROJECT SUMMARY
Although genome-wide association studies (GWAS) have discovered ~75 significant risk genes associated with
AD/ADRD, the underlying molecular mechanisms remain elusive. This gap has been partially filled by integrating
different omics data together with GWAS data. For example, tools developed can integrate transcriptome-wide
association study (TWAS) and proteome-wide association study (PWAS) with GWAS data to detect additional
AD risk genes and inform on their mediation via transcriptome or proteome with AD dementia. Yet, recent TWAS
and PWAS analyses for AD dementia have only considered cis-acting genetic regulations (Gap 1), generally
only used omics data from one tissue (Gap 2) and conduct TWAS and PWAS separately (Gap 3).
This study will extend and develop several new analytic tools that can be applied to genomic data from
multiple tissues. This will increase the number of AD risks genes identified from current TWAS/PWAS
studies and better inform on their molecular mechanisms. We will also validate AD risk genes identified
in this study using both computational methods and biological experiments in a model organism.
In Aim1, we will use our recently developed BGW method to estimate genome-wide cis- (nearby) and trans-
acting (distal) QTL effect sizes for transcriptome-wide genes and proteome-wide proteins in DLPFC and three
other tissues (Supplementary motor area (SMA), spinal cord, muscle). In Aim2, we will apply our recently
developed Stacked Regression based method to leverage these estimated genome-wide xQTL weights across
all four tissues, to improve the yield of separate tissue-specific TWAS and PWAS for AD dementia for the
target DLPFC tissue. In Aim3a, we will first develop a novel tool to conduct joint TWAS and PWAS in the same
analytic framework, which can test for genetic effects mediated by transcriptome while adjusting for PWAS
effects (and vice versa), and simultaneously test for genetic effects mediated by transcriptome-proteome
interactions. In Aim 3b, we will apply this novel tool to conduct joint genome-wide TWAS and PWAS for AD
dementia in the target DLPFC tissue. We will also explore secondary TWAS/PWAS analyses for other tissues
and combine the results by the omnibus Aggregated Cauchy Association Test (ACAT) across all four tissues to
provide secondary lists of significant risk genes of AD dementia. Aim 4, will validate AD risk genes identified,
by both computational approach with the probabilistic Mendelian Randomization tool (PMR-Egger, Aim 4a)
and biological experiments with the established Drosophila AD model (Aim 4b). We will examine the
underlying biological mechanisms of these validated significant risk genes by protein-protein interaction and
pathway analyses with STRING (Aim 4c). Public Health Impact: New tools developed in this study will
improve TWAS/PWAS studies to identify more risk genes for AD, better inform on their underlying mechanisms
and provide new targets for drug discovery for new AD therapies. This study can strongly impact ADRD as well
as genetic studies of other human diseases.

Public health relevance
PROJECT NARRATIVE Much of the genomic etiology of Alzheimer’s disease (AD) dementia is unexplained by current analytic genomic studies and so its underlying mechanisms are not well understood, thus impeding the development of new therapies. This project will develop and apply several new analytic tools to new streams of genomic data, with the goal of detecting additional AD risk genes that are missed by current tools and omics data, and better informing on their underlying genetic mechanisms. So, this study can provide new targets for mechanistic studies and drug discovery for new treatments to reduce cognitive impairment and AD dementia in millions of aging Americans.